WHCOHH Administrative Core

This Program Project application for the Woods Hole Center for Oceans and Human Health (WHCOHH) is for
renewal of a Center with a strong and integrated set of research projects that involve multiple disciplines in the
ocean and biomedical sciences, as well as communication of that research. The overall goal of the
Administrative Core is to maintain a structure to facilitate and ensure that communication, planning, and
interaction among Center members occur efficiently, so that the Projects and the Community Engagement Core
(CEC) are integrated and the goals and scientific objectives as set forth by the Project and Core leaders are
achieved. The multi-faceted activities of the Center will be overseen and guided by the Center Director and
Center Co-Director, through the Administrative Core. 1. The Core will oversee and monitor scientific, outreach
and financial aspects of the Center, including grants management, and assure compliance with data submission
and archiving policies for WHCOHH data. The Core will ensure that the communication and planning of Center
activities involve all Center Investigators and Co-Investigators, through regular meetings and an annual retreat
to consider research progress and integration and address problems and concerns as well as new
opportunities. 2. The Core will ensure effective community engagement and communication of WHCOHH
research, working with the CEC Director and Research Project Leaders to identify opportunities and ensure
involvement of Research Projects in community outreach and education, and engagement with stakeholders
and user groups, including resource managers, public health professionals and seafood harvesters and
consumers. 3. The Core will ensure cohesive and impactful evaluation and management of Center activities,
through Internal and External Advisory Committees, which will regularly review and evaluate the progress and
success of Center programs. We also will establish an advisory committee specific to the Community
Engagement Core, to advise on engagement practices. 4. We will maintain contact with relevant offices and
program managers at the NSF and the NIEHS, providing information on progress and responding to specific
requests. The Core will prepare and submit required reports to the NSF and the NIEHS in a timely manner. The
Core will facilitate regular interactions between the WHCOHH and other COHH4 Centers and will help organize
the broader COHH investigator meetings. We will pursue discussion with other Centers in the NIEHS portfolio,
engage collaborators on research relevant to the Center mission and themes, and begin discussion with OHH
centers elsewhere in the U.S. and internationally to broaden the impact of oceans and human health.